GANCICLOVIR (DHPG) FOR SYMPTOMATIC CONGENITAL CYTOMEGALOVIRUS INFECTIONS

This is a randomized, controlled trial to evalute the efficacy of treatment with DHPG (12mg/kg/day) Vs. no treatment in neonates with symptomatic congenital cytomegalovirus and CNS disease. Only babies with symptomatic congenital infection who stand to derive therapeutic benefit are eligible for the study.